Administrative Core

This Research Program Project, titled Omics signatures of transformative T-cell responses to
therapeutic vaccination against HIV (OmiT-HIV), will use samples from human clinical trials and
synergistic non-human primate studies to ask how therapeutic HIV vaccines can best elicit effective T-
cell responses from the chronically infected and antigen-exposed host immune system. The Program
has a strong multidisciplinary and international character, established by a team of expert PIs who are
longstanding collaborators and have access to unique human cohorts and novel approaches to therapeutic
vaccination of non-human primates. Such diversity, including geographic diversity, requires a strong
administrative structure to promote synergy between the programmatic elements by facilitating regular,
structured communication. This Administrative Core will provide overall organizational structure for the
Program Project, perform administrative functions, interface with NIH/NIAID staff, foster cooperation between
projects and with the Data Management and Analysis Core, encourage criticism and advice from its scientists
and ESAB, promote fiscal responsibility, and assure the continued excellence of the Project and its ability to
address the Specific Aims.
The Administrative Core will be based at UC Davis and led by Dr. Hartigan-O’Connor, one of the project’s two
MPIs. Dr. Hartigan-O’Connor previously led the administrative core for the RETIRE-HIV P01 at UC Davis,
which engaged many of the same personnel and performed similar functions. He is also co-PI of the large
U42 grant funding the Nonhuman Primate Testing Center for the NIH’s Somatic Cell Genome Editing
Consortium. Thus, Dr. Hartigan-O’Connor has abundant experience in management of large collaborative
projects such as this. The Core’s organization is supplemented by administrators, specialists, the External
Scientific Advisory Board, and an Internal Steering Committee.
The specific aims of the Administrative Core are:
1. Provide an organizational and programmatic structure to promote scientific excellence.
2. Provide organizational and financial oversight and future planning, establish decision-making processes, set
priorities, and resolve disputes
3. Ensure efficient data, information, and resource sharing.

Public health relevance
The Administrative Core provides organizational structure for the OmiT-HIV program project grant, which seeks to understand and improve immune responses to therapeutic HIV vaccines. If the program is successful then it will lead to better treatments for HIV infection, possibly including treatments that do not require daily ingestion of antiretroviral drugs. Through its administrative and oversight functions, this core will ensure the scientific excellence of the project and its ability to fulfill its aims.